Improving the reach and efficacy of gene therapy by in vivo EV targeting

The goal of this project is to extend the reach and efficacy of adeno-associated virus (AAV)-based gene therapy
by enlisting endogenously produced extracellular vesicles (EVs) to transport engineered transgene mRNA or
protein products among cells and across tissues. The motivation for this project is that many inherited disorders
are refractory to current AAV-based gene therapy for 1 of 2 reasons. First, the fraction of cells transduced by
AAV when administered systemically at a well-tolerated dose is limited and for some disorders may be insufficient
to rescue phenotype. Second, even if initial transduction efficiency is high, because AAV is non-replicating and
predominantly non-integrating, viral genomes tend to be lost quickly from cells in high mitotic tissues by simple
dilution due to repeated cell divisions as the child grows. Of note, booster shots are not a good option because
of neutralizing antibodies elicited by the initial dose. We propose a conceptually simple solution to these
problems: targeting intracellular transgene product – either as protein or as mRNA – to endogenous EVs
so that cells containing viral DNA will be able to share their expressed transgene product locally with
neighboring cells and systemically via transport through the bloodstream, including across the blood-
brain barrier. Specifically, we hypothesize that EV-facilitated transfer of transgene-encoded protein and/or
mRNA will increase the percentage of transgene product-positive cells in key tissues and will allow cells in low
mitotic tissues that retain viral DNA to share their expressed transgene product with cells in other tissues. Here,
we propose to test this hypothesis using an existing rat model of classic galactosemia administered scAAV9
virus encoding human galactose-1-P uridylyltransferase (GALT) either untagged or carrying 1 of 3 different EV-
targeting tags. The results of the proposed 2-year study will inform the direction of future research and set the
stage for application of this approach to gene therapy options for a large number of genetic disorders for which
there is currently no effective treatment.
1

Public health relevance
Gene therapy with adeno-associated viral vectors (AAVs) now offers a safe and effective approach to treatment for a growing number of genetic disorders; unfortunately, many disorders are refractory because of limited transduction rates and viral dilution over time in high mitotic tissues. Here, we propose to test the hypothesis that adding an EV-targeting tag to a virally-encoded transgene will significantly improve the distribution, duration, and efficacy of gene therapy in a GALT-null rat model of classic galactosemia. 1